Bayesian integration of biomarkers and spatial exposure data

DESCRIPTION (provided by applicant): Many environmental pollutants have distinct patterns in both space and time. One of the main challenges in epidemiologic studies of the health effects of these pollutants is characterizing those patterns accurately enough to rank study participants by the amount of pollutant exposure at any particular point in time or cumulatively over a given period of time. We propose new Bayesian statistical models to combine spatial and temporal exposure information from a variety of sources including source emissions, fate and transport models, exposure questionnaires, and biochemical measurements such as pollutant concentrations in participant's blood samples. Bayesian methods also produce quantitative estimates of the extent of uncertainty regarding each participant's amount of exposure. This characterization of uncertainty is critical for understanding the reliability of spatial epidemioloic analyses linking pollutant exposures to adverse health effects. We propose to further develop and implement these new Bayesian models using data from the C8 Health Project, a recent study of over 69,030 community residents exposed to perfluorooctanoate released from a major production facility in West Virginia. Previous analyses have associated perfluorooctanoate exposures in these study participants to pregnancy-induced hypertension/preeclampsia, testicular cancer, and kidney cancer; numerous other epidemiologic analyses are currently underway. These analyses all rely on the same set of exposure estimates, which estimate the extent of past exposure to each individual based on his/her residential and occupational history and tap water consumption, in conjunction with a complex set of linked spatial fate and transport models that estimate the past movement of perfluorooctanoate in the environment. Probability distributions will be used to characterize the uncertainty contributed by the various exposure model components for each consented participant in the C8 Health Project. Monte Carlo techniques will then be used to determine the combined effects of those uncertainties on the exposure estimates. These induced prior distributions will then be combined with perfluorooctanoate blood serum measurements obtained for the study participants in 2005-2006; the resulting combined posterior exposure estimates will be used to reanalyze the pregnancy-induced hypertension/preeclampsia association. These Bayesian models should 1.) improve exposure rankings for epidemiologic analyses and 2.) allow for direct characterization of the effects of spatial uncertainty on the reliability of epidemiologic findings.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many health studies for environmental pollutants depend on spatial information about the location of participants and pollutants over time, but it's generally impossible to obtain perfectly accurate spatial information. We propose to develop new statistical models to assess the accuracy of that spatial information and improve it by allowing its direct combination with biological measurements such as pollutant concentrations in blood. We will apply these new models to data from a large study associating perfluorooctanoate (a widespread environmental pollutant) with pregnancy-induced hypertension/preeclampsia (medical conditions that are life- threatening in extreme cases). __SpecificAimsTextDelimiter__ SPECIFIC AIMS Perfluorinated compounds are used in a number of consumer products such as Teflon, Gore-Tex, Scotchgard, among others. One of the compounds, perfluorooctanoate (PFOA or "C8"), has become ubiquitous in the environment over the last few decades and has been detected in over 95% of blood samples from the general US population that were collected in the National Health and Nutritional Examination Survey from 1999-2008 (Kato et al., 2011). PFOA has a variety of adverse health effects in high dose experiments with laboratory animals, including developmental toxicity, hepatotoxicity, and immunotoxicity (Lau et al., 2007). The C8 Health Project is an epidemiologic study of 69,030 people who consumed tap water from any of six PFOA-contaminated public water supplies located near a major U.S. fluoropolymer production facility located near Parkersburg, West Virginia. C8 Health Project participants constitute the most highly exposed sentinel population in the world, with 2005-2006 serum PFOA concentrations up to thousands of times larger than typically found in the US general population due primarily to contaminated drinking water (Frisbee et al., 2009). Numerous epidemiologic studies are being conducted with these participants (C8 Science Panel, 2012), including recent findings associating PFOA exposure with pregnancy-induced hypertension (PIH) and preeclampsia (Savitz et al., 2012a; Savitz et al., 2012b). Because 2005-2006 serum PFOA measurements do not well reflect historical exposures, these studies relied primarily on historical exposure reconstruction using annual PFOA emissions estimates, fate and transport models, public water pipe distribution network maps, and geocoded residential histories to assign dose estimates to each participant in each year. These spatiotemporal PFOA dose estimates have substantial uncertainty, but the extent and impact of that uncertainty on published associations with PIH/preeclampsia and other health outcomes has not been assessed. Moreover, the 2005-2006 serum measurements offer additional information regarding recent PFOA exposures to these individuals, but their combination with the other types of exposure information is not straightforward due to the complex temporal relationship between annual exposures and cross-sectional biomarker measurements. These data provide an opportunity for NIH to advance its goals expressed in the targeted funding opportunity PA-11-239, "Spatial Uncertainty: Data, Modeling, and Communication." In particular, our proposal addresses purpose B ("statistical methods to model spatial uncertainty... [including] methods for incorporating spatial uncertainty from various sources, such as physical activity, diet, food environment, etc."). We propose a Bayesian assessment accounting for uncertainties in the spatiotemporal exposure assignment: emissions estimates, fate and transport model components and their parameters, self-reported residential history and geocoding, matching of residential geocodes to public water supply networks, individual water usage variation, and non-residential and dietary PFOA exposures all contribute to this uncertainty. We will conduct literature reviews to establish prior distributions for these components then run Monte Carlo simulations to induce a meaningful joint prior distribution for the annual PFOA exposure estimates for all participants. The same logistic regression models used to associate PFOA exposure with PIH/preeclampsia among participants in the C8 Health Project will be repeated with these Monte Carlo iterates in order to determine the sensitivity of the published findings to the spatiotemporal exposure assignment. Finally, the spatiotemporal exposure estimates will be updated using the 2005-2006 biomarker data, using an explicit pharmacokinetic model to combine the two different types of measurements. These combined posterior exposure estimates will then be used in reassessment of PFOA PIH/preeclampsia associations using the C8 Health Project data. Posterior 95% prediction intervals will be reported, reflecting the combined multisource exposure data and their uncertainties. Aim 1: To develop meaningful joint prior distributions reflecting spatiotemporal uncertainty in retrospective PFOA exposure estimates for the C8 Health Project study population, based on fate and transport models, geocoded residential histories, public water distribution pipe networks, and water use questionnaires. Aim 2: To determine the sensitivity of previously reported C8 Health Project epidemiologic associations between PFOA and PIH/preeclampsia to spatiotemporal exposure uncertainty characterized by the prior distribution. Aim 3: To compute posterior distributions for PFOA exposure estimates and their uncertainty, combining the retrospective exposure estimates with individual PFOA serum measurements collected in 2005-2006. Aim 4: To test the hypotheses that PFOA and PIH/preeclampsia are associated in the C8 Health Project study population, accounting for spatiotemporal uncertainty through the use of Bayesian analysis.